An Integrated Biochemical and Structural Approach to Delineating the Biology of EWSR1

PROJECT SUMMARY
Fundamental cellular functions such as transcription, RNA processing, and DNA damage repair are achieved
through the correct spatial and temporal localization of biomolecular complexes containing dozens of different
protein and nucleic acid species. RNA-binding proteins that contain low-complexity amino acid sequences are
essential components of these complexes but also form pathological assemblies in neurodegenerative diseases
and pediatric cancers. The function of these low complexity sequences in healthy and disease states remain
poorly understood, partly because of the difficulty in obtaining high resolution structural information of the pro-
teins participating in these assemblies. The RNA binding protein Ewing sarcoma breakpoint 1 (EWSR1) is mem-
ber of a group of approximately 70 human RNA-binding proteins that contain intrinsically disordered low-com-
plexity regions that are deficient in charged amino acids but contain a high proportion of aromatic residues.
These low complexity regions self-associate, driving the assembly of dynamic clusters in a process commonly
referred to as liquid-liquid phase separation. EWSR1 primarily functions in mRNA processing and maturation
through the formation of dynamic, reversible complexes that provide a scaffold for, and promote the correct
spatial location of the processing machinery. Mutations in the low-complexity region cause uncontrolled assem-
bly of EWSR1 (and related proteins) forming pathological inclusions linked to the progression of amyotrophic
lateral sclerosis, frontal temporal dementia and related neuropathies. Further, through chromosomal transloca-
tions, the low-complexity domain of EWSR1 is joined to DNA-binding domains forming potent oncogenic fusions
responsible for the development of pediatric sarcomas. There is a paucity of molecular structural information on
the pathogenic function of EWSR1 and particularly how the low-complexity domain contributes to the oncogenic
properties of EWSR1-fusions. Recent technological advances in NMR spectroscopy now enable detection and
quantification of the dynamic, highly transient interactions that drive complex formation, thus providing the req-
uisite tool for determining the structure and function of EWSR1. This project will employ advanced NMR spec-
troscopic and other biophysical techniques, fluorescent and hydrodynamic methods, spectroscopic aggregation
assays and microscopy in conjunction with biochemical and biological assays to: (1) determine the molecular
events leading to EWSR1 self-assembly and biomolecular condensation; (2) define the structural details of how
the low complexity domain contributes to normal and abnormal EWSR1 functions; and (3) determine the role of
phase separation in the formation and stabilization of protein:DNA complexes involving the oncogenic EWS-FLI1
fusion protein. The results of our investigations will help advance our general understanding about macromolec-
ular assembly of dynamic protein/nucleoprotein complexes formed by low-complexity proteins. Understanding
the structural basis that defines their activity will guide the development of strategies to therapeutically target
low-complexity proteins or their molecular partners.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the multifunctional RNA-binding protein EWSR1 is associated with the neurodegenerative disease amyotrophic lateral sclerosis (Lou Gehrig’s Disease) as well as rare pediatric sarcomas (Ewing sarcoma). EWSR1 contains an intrinsically disordered, low complexity region implicated in its pathological functions. This project is relevant to NIH’s mission because defining the mechanistic and structural details of EWSR1 functions is the first step toward development of effective, targeted therapies for these diseases.